GENETIC AND EXPERIENTIAL INFLUENCES ON THE DEVELOPMENT OF PRIMATE VOCAL BEHAVIOR

This project is currently focusing on the hormonal, neural and pharmacological factors underlying vocal expression in nonhuman primates. Major findings this year include: 1. An autoradiographic study of the distribution of oxytocin binding sites in the brains of common marmosets found evidence for oxytocin specificity. Sites binding 125I-oxytocin show significant reduction in binding when co-treated with vasotocin (an oxytocin receptor antagonist), but not when co-treated with a ligand for vasopressin receptors. Further localization of forebrain receptor sites was made, with the most prominent encompassing the nucleus accumbens and olfactory tuberculum. A separate area occurs in the nucleus basalis/lateral amygdala region. 2. Hormonal status of single adult male squirrel monkeys living in proximity to a social group of females is correlated with changes in female vocal behavior. Females living adjacent to a male with high circulating testosterone level for 3 weeks showed a 10-fold increase in purrs and errs over pre-male introduction, whereas females living adjacent to a male with low testosterone level did not exhibit any change in their vocal behavior.